Assembly of Picornaviral Replication Complexes

DESCRIPTION (provided by applicant): The picornaviruses are a family of small positive sense single stranded RNA viruses that cause a wide range of diseases at an annual cost well into the hundreds of million dollars. Members include acute hepatitis A virus, the heart disease causing coxsackie B3 virus, rhinoviruses that cause more than half the occurrences of the common cold, and the paralyzing poliovirus. These viruses share a life cycle where RNA replication and viral assembly occurs in large membrane anchored replication complexes assembled on the surfaces of vesicles derived from the endoplasmic reticulum. The replication process is driven by a virally encoded RNA dependent RNA polymerase, the 3Dpol protein, that is responsible for the synthesis of all viral RNA. This research project is focused on the structure and assembly of viral replication centers, where we use poliovirus and coxsackievirus as our main experimental systems. We have previously solved the crystal structures of the 3Dpol proteins from both these viruses and elucidated the molecular mechanism behind the proteolytic activation of these proteins upon cleavage from the viral 3CDpro precursor protein. We are continuing our studies of picornaviral replication proteins by focusing on the structural changes associated with the formation of the 3Dpol elongation complex and on understanding how mutations in the polymerase affect viral RNA replication rate and fidelity both in vitro and in vivo. A new aspect of the project is focused on the structure and function of the membrane associated viral 2C and 2BC proteins that are responsible for host cell membrane rearrangements resulting in the formation of the vesicles upon which the viral replication complexes assemble. PUBLIC HEALTH RELEVANCE: Poliovirus is a member of a large family of viruses containing a specific RNA dependent RNA polymerase protein that is responsible for replicating the viral genome. The focus of this research project is to understand how this protein functions during virus replication and find ways to interfere with its function, which can open the door to the development of antiviral drugs.

Public health relevance
PROJECT NARRATIVE AI059130-06 Poliovirus is a member of a large family of viruses containing a specific RNA dependent RNA polymerase protein that is responsible for replicating the viral genome. The focus of this research project is to understand how this protein functions during virus replication and find ways to interfere with its function, which can open the door to the development of antiviral drugs.